Renal Anhydramnios Fetal Therapy (RAFT) Trial

Summary
The goal of this proposal is to evaluate the safety, feasibility and efficacy of serial amnioinfusions, a novel fetal
therapy for early pregnancy renal anhydramios (EPRA). EPRA occurs in more than 1 in 2000 pregnancies and
affects 1500 families in the U.S annually. EPRA has previously been considered universally fatal due to its
associated pulmonary hypoplasia and neonatal respiratory failure. More recently, preliminary data from case
reports have demonstrated an association between serial amnioinfusion therapy and short-term postnatal
survival in EPRA fetuses, with excellent respiratory function in the neonatal period. Furthermore, long-term
survival has been observed in a few cases, largely due to advances in neonatal dialysis and the advent of safe
living donor kidney transplantation in toddlers. Serial amnioinfusions for the management of EPRA have been
implemented in clinical practice, but no systematic and prospective study evaluating this treatment has
occurred. Therefore, there is a lack of generalizable knowledge about the maternal/fetal safety, feasibility and
short- and long-term clinical outcomes of this intervention. This proposal to study Renal Anhydramnios Fetal
Therapy (RAFT) consists of a multi-center, non-randomized prospective trial to address the following specific
aims: (1) To determine the maternal and fetal safety and feasibility of serial amnioinfusions for EPRA
(2) To examine the short-term efficacy of RAFT and (3) To determine the long-term efficacy of RAFT on
survival and quality of life. A consortium of 8 advanced fetal centers will operate under a single institutional
review board with one protocol that has strict inclusion and exclusion criteria. Each center has been selected
based on long experience and expertise in advanced fetal therapy and neonatal dialysis. This pilot trial will also
seek to elucidate the mechanism of RAFT by capturing radiologic and amniotic fluid biomarkers during therapy.
Furthermore, it will permit the first prospective analysis of the in utero natural history of EPRA by rigorously
tracking patients who do not terminate their EPRA pregnancy but do not wish to undergo serial amnioinfusions.
The RAFT trial not only has the potential to improve our understanding of the effect of serial amnioinfusions on
lung growth in EPRA but also on other fetal diseases that impair lung function. Furthermore, serial
amnioinfusions in EPRA pregnancies and serial acquisition of amniotic fluid biomarkers along with assessment
of radiologic biomarkers may shed new light on the mechanisms of normal lung development. Most
importantly, this trial will provide crucial data to assist families in making decisions about fetal therapy for
fetuses affected by EPRA, making incremental progress toward the goal of health from birth for all children.

Public health relevance
Project Narrative Early onset anhydramnios from fetal renal failure, which affects > 1 in every 2000 pregnancies in the United States per year, leads to pulmonary hypoplasia that is fatal in the neonatal period. This multicenter prospective trial will rigorously test the first ever viable therapy of serial amnioinfusions, to assess short- and long-term safety, feasibility and efficacy to treat this fatal disease. This work will fill critical gaps in knowledge and help optimize the chance that fetuses with early onset anhydramnios are born as healthy as possible with the best chance of long-term survival.